CHEMICAL STRATEGIES FOR CONFORMATIONAL CONTROL OF BIOACTIVE PEPTIDES

PROJECT SUMMARY
To realize the potential of peptide- and protein-based therapeutics, conformational control is essential. Current
strategies focus on either optimizing the amino-acid sequence toward a desired structure or creating covalent
bonds between amino-acid side chains to restrict conformational flexibility. Though these strategies have
demonstrated important successes, they require extensive optimization and limit the availability of side-chain
functionalities that could instead be optimized for target engagement. A central goal of our laboratory is therefore
to develop more general strategies to specify peptide/protein structure. To do so, we will evaluate new chemical
approaches to preorganize individual amino acids without sacrificing side-chain functionality. Inspired by
differences in the conformational propensities of natural amino acids, we will synthesize minimally modified
amino-acid analogs that favor specific secondary structures. Initial priorities include the synthesis of amino-acid
analogs that modify their proteinogenic counterparts’ intrinsic propensities to adopt beta-sheet secondary
structures. We are also interested in controlling the conformation and interactions of glycine residues, which
play a unique role in protein structure and yet remain difficult to constrain. After synthesizing a suite of novel
amino-acid analogs, we will evaluate their conformational propensities by studying the folding thermodynamics
of model peptides/proteins that incorporate these residues. We will also evaluate the ability of peptides
incorporating modified amino acids to engage with important biological targets, especially misfolded proteins
and transmembrane helices. Our results will inform the design of peptides and proteins with improved
conformational control, thereby supporting a variety of applications across medicine and biotechnology.

Public health relevance
PROJECT NARRATIVE Peptides and proteins hold immense potential as therapeutics, but controlling their structure remains a general challenge. Current strategies require extensive optimization and/or sacrifice useful side-chain functionalities, thereby limiting bioactivity. In this project, we will evaluate new chemical strategies for controlling peptide structure for applications across biotechnology and medicine.